Targeting metabolic stress response to improve CAR-T cell efficacy.

Project Summary
T cell-based immune therapies are a promising approach to treat cancer. Chimeric antigen receptor (CAR) is
one such therapy developed by engineering a protein comprised of a tumor recognition motif, a T cell major
signaling molecule, and costimulatory molecules. Engineered T cells expressing CAR (CAR-T cells) have shown
remarkable clinical success in treating B cell malignancies, but their efficacy in controlling solid tumors is
limited. The major hurdle to T cell treatments is overcoming their chronic stimulation and CAR-T cell
exhaustion. Chronic T cell activation induces oxidative stress and accumulation of stress granules (SG). SG are
subcellular cytoplasmic compartments that contain RNA-binding proteins and translationally repressed
mRNAs. Significant progress has been made in understanding the components of the SG core and uncovering
the therapeutic potential of SG regulators in cancer and neurodegenerative diseases. However, the functional
role of the T cell SG network in T cell exhaustion and the mechanistic link between the SG core and CAR-T cell
exhaustion are completely unknown. We propose to test the hypothesis that augmentation of the SG
regulatory network leads to CAR-T cell exhaustion. Using our recently devised CAR construct with a
fluorescence reporter to track SG assembly and maintenance in living cells, we will analyze the SG dynamics of
activated and exhausted CAR-T cells when the SG core regulator, G3BP1, is downregulated. We will measure
how effective the G3BP1-downregulated CAR-T cells are in controlling tumor cell growth in vitro and in vivo to
determine if the G3BP1 downregulation improves CAR-T function and longevity. Next, we will target upstream
metabolic stress regulators to test whether CAR-T cell function improves when metabolic stress regulators are
deficient. Our innovative proposal to explore the T cell SG network, the translational regulators of metabolic
stress as regulatory targets to improve CAR-T cell longevity, and the mechanistic tie between the SG network
and CAR-T cell addresses a critical gap in the field. This project is expected to provide novel insights into an
unexplored area of T cell biology that will not only spur a better understanding of this process but will facilitate
the development of novel cancer therapeutics.

Public health relevance
Project Narrative Immunotherapies with genetically engineered T lymphocytes are successful in controlling the growth and spread of blood cancers but are not effective against solid cancers. We will test the hypothesis that oxidative stress-induced molecular changes in these T cells reduce their ability to kill cancer cells. Our goal is to develop a new version of engineered T cells with reduced stress-induced molecular changes to improve T cell function and therapeutic efficacy against solid cancers.